Leveraging the sensitivity of antigen-specific T cells to interrogate disease mechanisms and identify therapeutic targets for Long COVID

Project Summary/Abstract: An estimated 400 million people worldwide have experienced persisting and
sometimes debilitating symptoms for months and years after SARS-CoV-2 infection, known as Long COVID
(LC). No proven therapies exist to treat LC, and the underlying mechanisms driving disease remain poorly
understood. Reactivation of herpesviruses such as Epstein-Barr virus (EBV) and varicella zoster virus (VZV) has
been linked to LC, but it is unclear how SARS-CoV-2 infection alters immune responses to these common
viruses. Recent studies have also provided emerging evidence for persistence of SARS-CoV-2 in some
individuals with LC, but key questions remain unanswered, including how viral reservoirs persist, why the
immune system fails to clear virus, whether persisting virus drives ongoing immune stimulation, and how
therapies to treat LC will affect immune responses to SARS-CoV-2. Efforts to identify effective treatments for LC
depend on answering these questions. Our preliminary data demonstrate elevated activation of SARS-CoV-2-,
EBV-, or VZV-specific T cells in 40% of LC patients, providing one of the most sensitive measures of
immunopathology in LC to date. Thus, there is an urgent need to investigate virus-specific T cell activation in LC
to define underlying mechanisms of disease and identify promising therapeutic targets. The proposed research
will respond to this need by testing three working hypotheses: first, that SARS-CoV-2-specific CD8 T cells survey
tissue reservoirs of SARS-CoV-2 and sense viral antigens, but fail to clear the virus due to impaired functionality
in LC; second, that therapies suppressing SARS-CoV-2 replication will reduce T cell stimulation in LC but may
not achieve a durable cure; and third, that immune stimulation by common herpesviruses is associated with
disease pathology in LC. These hypotheses will be tested by leveraging custom HLA-I/peptide tetramers to
identify and sort rare virus-specific CD8 T cells from hundreds of longitudinal blood and tissue samples from
people with LC and people who fully recovered after SARS-CoV-2 infection. Cells will be analyzed using spectral
flow cytometry and single-cell sequencing approaches to elucidate the mechanisms driving LC pathology,
identify promising therapeutic targets for LC, and investigate how immune stimulation by herpesviruses shapes
human disease. This research will be integrated with a comprehensive training plan to develop skills in tissue
immunology, single-cell sequencing, and bioinformatics, which will be reinforced with targeted coursework and
professional development activities in scientific writing, responsible conduct of research, laboratory
management, and mentorship of junior personnel. The research and training plan will take full advantage of the
outstanding environment at the University of Pennsylvania and the wealth of expertise in Dr. John Wherry’s lab.
Completing the proposed research and training will substantially advance the human immunology field and form
the foundation of my research program as I open my independent laboratory, creating a pathway to my goal of
being an impactful independent researcher in human infectious disease immunology.

Public health relevance
Project Narrative It is estimated that as many as 400 million people worldwide may have experienced Long COVID (LC), which is characterized by persistent and sometimes debilitating symptoms that can last for months or years after initial SARS-CoV-2 infection. No proven therapies have been identified for LC due to the poor understanding of the mechanisms driving the condition, but emerging evidence suggests that persistent reservoirs of SARS-CoV-2 and reactivation of common herpesviruses can be associated with LC. This study of longitudinal blood and tissue samples from hundreds of individuals will leverage the exquisite sensitivity of virus-specific T cells to interrogate T cell responses to viral reservoirs, inform the success or failure of antiviral therapies, assess how herpesvirus antigens drive inflammatory disease in LC, and identify potential immunotherapeutic targets to treat or cure LC.